Prevention of Candida biofilms by localized delivery of aurein analogues

ABSTRACT Candida spp. are the most common fungal pathogens isolated from humans and are leading causes of hospital-acquired infections, largely due to colonization of indwelling medical devices including catheters. Current strategies to prevent Candida spp. infections associated with medical devices include systemic antifungals, but these drugs suffer from severe toxicity and side effects, and drug-resistant strains have emerged. The goal of our project is to develop a novel strategy to prevent C. albicans biofilm formation on catheters by designing a new antifungal drug structurally templated on the natural broad-spectrum antimicrobial peptide (AMP) aurein 1.2. Like many AMPs, aurein 1.2 adopts a helical structure and selectively permeabilizes microbial membranes via cationic and hydrophobic interactions. However, efforts to develop AMPs into drugs have been largely unsuccessful since these compounds possess low stability in physiologic environments. Here, we propose to synthesize α/β-peptide aurein 1.2 mimetics which exhibit folding patterns that present side chains in virtually identical manner to native AMPs, and thus allow the use of α/β-peptide analogues templated on native antimicrobial peptide sequences as lead compounds. α/β-peptides are much more structurally stable than native antimicrobial peptides and are resistant to proteolytic degradation, offering significant advantages for drug development. Furthermore, we propose to develop a strategy to release this drug from catheter surfaces, localizing the treatment to inhibit biofilm formation. In prior work the PI identified that cationic, amphiphilic oligomers of β-amino acids (called β-peptides) can exhibit high levels of specific activity against C. albicans as compared to mammalian cells, although efforts reached a limit of potency and specificity. Collaborations with co-investigators on this project demonstrated sustained release from catheter surfaces and inhibition of biofilm formation in vitro and in vivo. Here, we will extend our findings and approach to α/β-peptides which are composed of both α? and β-amino acids. In the first two years of this project (R21 phase) we will generate α/β-aurein analogues and determine how varying hydrophobicity, net charge, and helical stability affect activity against drug-resistant C. albicans and specificity for C. albicans vs. mammalian cells. Then we will assess whether release of these compounds from polyelectrolyte multilayer (PEM) polymer films on a catheter surface inhibits C. albicans biofilm formation in vitro and in vivo. The remainder of the project (R33 phase) will further vary α- and β-amino acid sequence and combine features of α/β-aurein analogues identified to affect activity and specificity in C. albicans to optimize broad-spectrum antifungal activity and specificity in additional pathogenic Candida spp. Finally, we will develop polymer film-mediated release of the α/β-aurein analogues for sustained inhibition of Candida spp. biofilms in an in vitro model and then evaluate effectiveness of biofilm prevention in a rat model of central venous catheter infections. Together, these results will develop a novel strategy for prevention of device-associated candidemia.

Public health relevance
HEALTH RELEVANCE We propose to design α/β-peptide mimetics of the sequence and structure of the natural antimicrobial peptide aurein 1.2 that exhibits broad spectrum activity against pathogenic microbes, and to develop and implement a polyelectrolyte multilayer (PEM) polymer film-based platform to deliver these α/β-aurein analogues from a catheter surface with the goal of preventing biofilms formed by Candida species, including drug-resistant strains. As part of our research approach, we will engineer the structure of α/β-aurein analogues to optimize antifungal activity and specificity for fungal cells vs. mammalian cells. Finally, we will evaluate α/β-aurein analogues against multiple Candida species using in vitro and in vivo models of catheter associated infections with the goal of effective and safe long-term prevention of fungal biofilms.